MicroRNAs in Kidney Progenitor Cells.

Project Summary/Abstract MicroRNAs (miRNAs) are a group of novel small RNAs that regulate gene expression via the post- transcriptional repression of specific target mRNAs. As a group, miRNAs play a key role in diverse developmental processes, and are required for the differentiation of embryonic stem cells; however the function of miRNAs during kidney development remains largely undefined. Our preliminary work indicates that the loss of miRNAs within the nephron progenitor compartment of the developing kidney results in a premature depletion of this population, and as a consequence, a marked decrease in nephron number. Furthermore, this is accompanied by elevated expression of the pro-apoptotic protein Bim (also known as Bcl-2L11) specifically in nephron progenitors, and an increase in apoptosis in this cell population. We propose that specific miRNAs promote the survival of nephron progenitors by regulating the expression of Bim, and that this mechanism represents a means of determining congenital nephron endowment during normal kidney development. Specific aim 1: To characterize the role of Bim (Bcl-2L11) in the survival of nephron progenitors during kidney development. Specific aim 2: To define the function of the miRNA clusters, mmu-miR-106b~25 and mmu- miR-17~92, in regulating Bim expression and nephron progenitors. Specific aim 3: To determine the functional role of mmu-miR-10a during kidney development. The work proposed in this grant will serve as the foundation for the PI's transition into an independent career as a physician-scientist in an academic pediatric renal division over the next two years. The mentored phase (K99) will occur at Children's Hospital Boston and Harvard Medical School under the guidance of Dr. Jordan Kreidberg.

Public health relevance
Project Narrative Together, these studies will further our understanding of the molecular and cellular processes that regulate nephron progenitors in establishing the full complement of nephrons during kidney development. This will ultimately inform the pathophysiology underlying congenital renal anomalies, the leading cause of renal failure in young children, and the mechanisms that determine congenital nephron number, which has important implications for long-term kidney health. __SpecificAimsTextDelimiter__ eerhPan 10. Specific Aims irRA mRA)aeanvlcaso ml Nsta euaegn xrsintruhte post-transcriptional repression of specific target mRNAs. As a group, miRNAs play a key role in diverse developmental processes, and are required for the differentiation of embryonic stem cells; however the function of miRNAs during kidney development remains largely undefined. My preliminary work indicates that the loss of miRNAs within the nephron progenitor compartment of the developing kidney results in a premature depletion of this population, and as a consequence, a marked decrease in nephron number. Furthermore, this is accompanied by elevated expression of the pro-apoptotic protein Bim (also known as Bcl-2L11) specifically in nephron progenitors, and an increase in apoptosis in this cell population. I hypothesize that specific miRNAs promote the survival of nephron progenitors by regulating the expression of Bim, and that this mechanism represents a means of determining congenital nephron endowment during normal kidney development. I am interested in understanding the functional consequences of alterations in Bim activity on nephron progenitors, and the identification of the specific miRNAs that target Bim and other mRNAs in the context of nephron progenitor self-renewal and differentiation. Specific aim 1: To characterize the role of Bim (Bcl-2L11) in the survival of nephron progenitors during kidney development. Since my preliminary data demonstrates that the loss of miRNAs in nephron progenitors is associated with increased apoptosis and Bim expression in this population, yohsz htteblnebtente r-ppoi rti i n h r-uvvlpoenBl sciia ndtriignprnpoeio uigkde eeomn.t I will use an xvvoembryonic kidney organ culture model system to perturb the balance between Bim and Bcl2 with morpholino knockdowns and a gain-of-function Bim peptide analog to evaluate the functional consequences on nephron progenitors. To further characterize this interaction nvv,oI will analyze the effects of loss-of-function of Bim and Bcl2 in transgenic mouse models on nephron progenitors. To test whether Bim expression is more generally a target of known regulators of the nephron progenitor population, I will examine Bim expression in a transgenic conditional shRNA-Wt1 knockdown mouse model. Specific aim 2: To define the function of the miRNA clusters, mmu-miR-106b~25 and mmu-miR-17~92, in regulating Bim expression and nephron progenitors. Because members of the mmu-miR-106b~25 and mmu-miR-17~92 miRNA clusters have been shown to target the Bim transcript in other organ systems, yohsz htteemRAcutr euaeBm xrsinadnprnpoeio uvvlTo define the function of these miRNAs on the nephron progenitor population, I will use a morpholino knockdown approach in xvvoembryonic kidney organ cultures for individual miRNAs and transgenic loss-of-function mouse models for each miR cluster to assess the effects on the nephron progenitors and Bim expression. Furthermore, I will utilize these two models to identify novel targets of these miRNAs in the embryonic kidney. Specific aim 3: To determine the functional role of mmu-miR-10a during kidney development. mmu-miR-10a is expressed specifically in nephron progenitors in the embryonic kidney and is predicted to target Bim activity using bioinformatics prediction algorithms. Moreover, my preliminary data demonstrates that morpholino knockdown of mmu-miR-10a expression results in a significant phenotype in embryonic kidney organ culture. yohsz htmumR1ai rca nnprnpoeiosdrn inydvl pet. I will create a transgenic mouse that over-expresses mmu-miR-10a in nephron progenitors using a Cre- loxP strategy. The transgenic mouse model and the xvvoembryonic kidney organ cultures will be used to characterize the functional role of mmu-miR-10a in nephron progenitors, specifically to examine its ability to regulate Bim expression, and to identify biologically important mmu-miR-10a targets in the embryonic kidney. Together, these studies will clarify the impact of miRNAs on the survival of nephron progenitors, with a focus on the pro-apoptotic protein Bim. This information will improve our knowledge of the molecular mechanisms by which miRNAs regulate the self-renewal and differentiation of nephron progenitors during kidney development. This research will ultimately inform the pathophysiology underlying congenital renal anomalies and the determination of congenital nephron number, questions with significant implications for kidney health in childhood and beyond.